Cellular and Molecular Mechanisms of Atherosclerosis

Atherosclerotic cardiovascular disease (CVD) remains the leading cause of death worldwide and substantial
residual CVD risk persists despite effective LDL-cholesterol (LDL-C) lowering. In this context, we propose an
investigation of mechanisms of plaque stabilization and destabilization focused on novel functions of
macrophages (Mϕ) and vascular stromal cells, and their crosstalk, in mouse models and human CVD. Our
overarching hypothesis, pursued through three highly integrated Projects and two Scientific Cores is that
inflammation and the efferocytosis-resolution cycle in macrophages regulate plaque stability through crosstalk
with other macrophages and stromal cells and that detailed examination of the cell and molecular mechanisms
may provide opportunities for novel CVD treatments, including in patients with clonal hematopoiesis, an
emerging CVD risk factor. To address this hypothesis, Aim 1 will assess novel genes and pathways regulating
macrophage efferocytosis in atherosclerosis and mechanistically based therapeutic approaches to improve
efferocytosis and stabilize plaques. Aim 2 will investigate the impact of inflammatory cross-talk from Mϕs to
stromal cells on plaque fibrous cap formation. Aim 3 will pursue translational relevance by examining the
relationship of clonal hematopoiesis mutations and efferocytosis genes to features of plaque stability using
human carotid plaque samples from the Munich Vascular Biobank. We will pursue these overall aims in three
highly integrated Projects, and two Scientific Cores coordinated by our Administrative Core. Our program will
use mouse models of disease and human atherosclerotic plaques to assess multiple genetic and therapeutic
interventions designed to stabilize plaques and reduce CVD risk. The projects will extensively leverage the
Scientific Cores to apply harmonized bioinformatic methods to single cell -omics data (Core B: Bioinformatics
and Biostatistics) and atherosclerosis phenotyping of mouse and human lesions(Core C: Mouse and Human
Atherosclerosis Tissue Core). Cross-cutting biological and technical innovations include mice that accurately
model clonal hematopoiesis, cell lineage tracing mouse models, advanced bioinformatics for sc and spatial data,
and new spatial transcriptomics approaches in human carotid plaques. Collaboration permeates the entire PPG
as a result of three years of preparatory work and preliminary studies. Each project addresses complementary
questions that together provide opportunities to understand new clinically relevant paradigms of atherosclerosis
stability and instability with the expectation to provide opportunities for novel mechanism-based targeted
therapeutic intervention to reduce CVD beyond LDL-C lowering. Thus, our proposed PPG is mechanistically,
clinically and translationally significant and relevant to public health.

Public health relevance
NARRATIVE Atherosclerotic cardiovascular disease (CVD) remains the leading cause of death worldwide and substantial residual CVD risk persists despite effective LDL-cholesterol (LDL-C) lowering. In this context, we propose an investigation of mechanisms of plaque stabilization and destabilization focused on novel functions of vascular macrophages and stromal cells, and their crosstalk, in mouse models and human CVD. Our overarching theme, pursued through three highly integrated Projects and two Scientific Cores is that inflammation and the efferocytosis-resolution cycle in macrophages regulates plaque stability through crosstalk with other macrophages and stromal cells and that detailed examination of the cell and molecular mechanisms may provide opportunities for novel CVD treatments, including in patients with clonal hematopoiesis, an emerging CVD risk factor.